Estrogen receptor signaling, inflammation and ozone toxicity

PROJECT SUMMARY (See instructions):
Macrophages contribute to ozone toxicity by regulating both the initiation and resolution of lung
inflammation; these processes are mediated by distinct macrophage subpopulations broadly classified as
proinflammatory/cytotoxic (M1) and anti-inflammatory/wound repair (M2) macrophages. M1 and M2
macrophage activation is controlled, in part, by intracellular metabolism; thus, while high glycolytic capacity
is associated with M1 activity, increases in fatty acid oxidation and mitochondrial oxidative phosphorylation
are required for M2 macrophage activation. New data suggest that ozone toxicity is due to impaired M2
activation and a failure to resolve inflammation, however, mechanisms are not known. A preliminary RNAseq analysis of lung macrophages collected after ozone exposure revealed significant enrichment of the
estrogen receptor signaling pathway among differentially expressed genes. This was associated with an
increase in glycolytic metabolism and down-regulation of PPARγ expression, a transcription factor known
to promote M2 phenotype and resolution of inflammation by shifting intracellular metabolism to fatty acid
oxidation. Estrogen has been shown to regulate PPARγ expression by activating estrogen receptor alpha
(ESR1) located at the cell membrane, and to promote macrophage anti-inflammatory activity by shifting
metabolism to fatty acid oxidation; we speculate that this pathway is important in macrophage responses to
ozone. We hypothesize that ozone interferes with extra-nuclear ESR1 signaling in macrophages and
downstream activation of PPARγ; this leads to impaired fatty acid oxidation and M2 macrophage
activation resulting in aberrant resolution of inflammation and increased tissue injury. Two aims are
proposed to test this hypothesis. In the first aim, I will analyze the role for ESR1 signaling in macrophage
immunometabolism and phenotypic activation. Aim 2 will focus on 1) elucidation of mechanisms by which
ozone interferes with extra-nuclear ESR1 signaling, 2) the role of extra-nuclear ESR1 in macrophage
bioenergetics and phenotype in response to ozone and how this influences lung injury, and 3) developing
strategies to mitigate ozone-induced lung injury by rescuing extra-nuclear ESR1 signaling. Results of these
studies will provide novel data on general mechanisms underlying macrophage responses to inhaled ozone
and mechanistic evidence supporting sex-based differences in pulmonary responses. Findings that ESR1
is critical in these pathways will highlight estrogen signaling as a key driver of sexual dimorphism in lung
disease and indicate that individualized exposure limits and therapeutic strategies may be required to
prevent disease and to target distinct pathways driving toxicity in men and women. I will leverage my
training in macrophage biology, ESR1 signaling, bioinformatics, and intracellular metabolism acquired
during the K99 award period to develop an independent research program at my new institution focused on
elucidating estrogen receptor signaling networks regulating inflammation in environmentally induced lung
disease.

Public health relevance
RELEVANCE (See instructions): Ozone is a ubiquitous urban air pollutant that causes significant cardiopulmonary morbidity in healthy and susceptible individuals, including children and the elderly. Our studies are focused on elucidating the role of estrogen receptor signaling in macrophage inflammatory responses to ozone which are known to be important in tissue injury and disease pathogenesis. Results may lead to the development of novel strategies for mitigating disease burden and will better inform regulatory guidelines.